The Development of the RGC Projectome

Project Summary
During embryogenesis, retinal ganglia cells (RGCs) from both eyes grow axons towards the brain to establish
proper vision. Disruptions in this process can lead to permanent visual defects. Despite its importance, we lack
comprehensive models describing how 100,000’s of RGC axons faithfully grow in the proper direction. Most
current approaches sample few (<1%) of RGCs and little of the surrounding cellular milieu. We propose to
address this gap by leveraging advances in large volume serial electron microscopy (vEM) connectomics and
genetic labeling techniques to produce nanoscale 3D maps of how every individual RGC axon develops
embryonically from optic nerve to tract during and their resulting adult organization. We will label functional
subgroups of RGCs to test hypotheses functionally similar axons travel and develop together. This project will
generate unprecedented data on the formation of an critical component of the early visual system, laying the
groundwork for targeted interventions aimed at preventing or reversing developmental circuit abnormalities or
damage.

Public health relevance
Project Narrative During embryogenesis, 100,000’s of retinal ganglia cells (RGCs) from both eyes precisely grow axons long distances to make appropriate connections. Defects in this program can result visual abnormalities but we know very little about this process and the resulting organization in the adult. This proposal seeks to better understand RGC axon guidance by mapping the development of every individual RGC axon and its adult organization, with functional specificity.